Elevating efforts to recruit and retain HBCU scholars in the field of aging

ABSTRACT
Population aging suggests the need for a diverse workforce of community advocates, academic scholars, health care
providers, and other professionals with training in gerontology/geriatric medicine or a related discipline. Established in the
early 19th century, Historically Black Colleges and Universities (HBCUs) were created to educate Black students when they
were not allowed to attend certain public and/or private predominately white institutions. With increasing enrollment,
HBCUs are now being recognized for their progressive academic presence in the Black community educating distinguished
scientists, inventors, politicians, and world leaders. These institutions have similarly become increasingly integrated into
the aging network by educating (undergraduate/graduate) some of the most influential Black gerontologists and geriatric
practitioners. Despite the role of HBCUs in educating and preparing established and emerging scientists, there remains
limited professional development opportunities, a lack of scholarly resources, and inadequate mentoring and networking
supports for HBCU scientists by established (Black) gerontologists. To address these issues, the Gerontological Society of
America’s (GSA) HBCU Collaborative Interest Group and Black in Gerontology and Geriatrics (BIGG) will collaborate to
organize and host conferences for emerging and early career scientists from HBCUs. The aims of the HBCU aging
conference series are to: host five multidisciplinary annual conferences; address knowledge gaps and identify future
priorities in gerontology related to minority/Black aging; prepare scientists for leadership positions/roles in gerontology;
facilitate professional development, mentoring, and networking opportunities within and between HBCUs, and other
community-based and academic institutions; and sponsor a select number of emerging and early career scientists from
HBCUs to attend and participate in the annual conference through the HBCU Aging Ambassadors Program (HAAP). Each
conference will be an interactive two-day pre-conference workshop during the GSA’s annual scientific meeting. All
attendees will be engaged with panel discussions, professional development breakout sessions, and facilitated mentoring
and networking opportunities. This conference series will serve as an essential hub for knowledge transfer and exchange,
professional skills and practice improvement, sustainable best practices in gerontology, proficiency in established
competencies, and transformation in the quality of aging scholarship. The novelty of these conferences is that, to our
knowledge, it is the first to focus exclusively on scientists engaged in gerontology or a related discipline from HBCUs, and
it aligns with NIH’s mission to diversify the scientific workforce, while engaging minority serving institutions (e.g.,
HBCUs) in research and addressing racial inequities across the biomedical research establishments.

Public health relevance
PROJECT NARRATIVE There is a need for a racially diverse workforce of gerontologists. HBCUs are well integrated in the discipline, but with limited resources. This conference series will provide professional development and networking opportunities for HBCU emerging scientists, while ensuring that aging communities have access to culturally competent and equitable care.